Molecular basis of antibiotic resilience in Mycobacterium tuberculosis

Summary
We have identified a novel driver of treatment failure in Mycobacterium tuberculosis, termed antibiotic
resilience, where the bacteria have improved recovery after antibiotic exposure. Population genomic and
genetic studies implicate a novel transcriptional regulatory network in control of antibiotic resilience, which we
will dissect through genomically informed structure-function studies and in treatment models.

Public health relevance
Narrative Mycobacterium tuberculosis (Mtb) has been subject to antibiotic selection in human populations for almost 80 years. We have used population genomics to identify Mtb genes undergoing diversifying selection in clinical strain since the onset of antibiotics. By phenotyping isogenic Mtb strains engineered to carry clinically prevalent variants, we have uncovered a new form of altered drug susceptibility, a recovery phenotype that we call antibiotic resilience. Mtb strains with resilience mutations which are subject to a period of drug exposure recover and begin to grow significantly more rapidly than wildtype strains. We have identified clinically prevalent resilience mutations in four essential regulators and their binding sites; we further find that these regulators regulate each other in modulate expression of key cell growth and division genes. Here we will mechanistically dissect the transcriptional regulatory network underlying antibiotic resilience through three aims: (1) “Define the resilience regulatory response under drug and host relevant conditions” in which we will generate and transcriptionally profile Mtb strains with resilience mutations; (2) “Determine the mechanistic basis of network-associated transcription factor functions under drug- and host-relevant conditions” in which we will use biochemical and structural approaches to determine the functions of the regulators with novel mechanisms of action and the impact of the clinically prevalent variants; and (3) In mouse models, “Test the hypothesis that antibiotic resilience mutations allow Mtb to escape drug and host selection in vivo”. These studies will elucidate the genomic and protein changes underlying resilience, a clinically relevant, previously unrecognized form of drug escape in Mtb, and our findings may inform future treatment and surveillance strategies for TB.